Molecular characterization of lipofuscin pathology in neuronal ceroid lipofuscinosis

PROJECT SUMMARY/ABSTRACT
Neuronal ceroid lipofuscinosis type 1 (CLN1) is a devastating neurodegenerative disease with infantile onset.
CLN1 is caused by loss-of-function mutations in palmitoyl protein thioesterase 1 (PPT1), a critical
depalmitoylating enzyme in the brain. CLN1 and other genetic forms of this disorder (NCLs) are characterized
by common clinical symptoms and neuropathological hallmarks. Symptoms include seizures, vision loss, and
progressive motor and cognitive decline, while the brains of NCL patients exhibit cortical neuron loss, retinal
degeneration, and the accumulation of lipofuscin, an autofluorescent lysosomal storage material with largely
undescribed composition. The understanding of the molecular basis of CLN1, and hence the development of
treatments, has been hindered by the limited repertoire of known PPT1 substrates. We recently identified more
than 100 novel PPT1 substrates and documented a small subset of lysosomal proteins that are both highly
upregulated and palmitoylated at early-stage disease in a CLN1 mouse model. Strikingly, these proteins include
causal genes and genetic modifiers of NCLs and other lysosomal storage disorders. Further, these salient NCL
proteins remain upregulated as CLN1 progresses, and are found, along with validated PPT1 substrates, to
accumulate in proteomic datasets of human age-related lipofuscin. These data strongly suggest that CLN1,
other forms of NCL, and pathological aging share common molecular mechanisms. However, it remains unclear
why this subset of lysosomal storage disorder proteins accumulates in CLN1 and during aging and how they
contribute to lipofuscin pathology. The proposed research takes advantage of a key opportunity to dissect these
putative etiological relationships.
In Aim 1, I will determine if NCL proteins are PPT1 substrates with in vitro depalmitoylation assays and uncover
if CLN1 is accompanied by deficits in the lysosomal functions of NCL proteins with hydrolase activity panels.
This aim will thus expand the known PPT1 substrate repertoire and detail critical mechanistic links between
NCLs. The degradation, trafficking, and lysosomal compartmentalization of NCL proteins will then be tested in
Aim 2 using cycloheximide chases, live-cell imaging, and immunocytochemistry. Regardless of whether NCL
proteins are PPT1 substrates, this approach will provide a mechanistic basis for their upregulation. Finally, in
Aim 3, the composition of CLN1 lipofuscin, including the constituency of NCL proteins and palmitate lipids, will
be assessed with electron microscopy and state-of-the art mass spectrometry techniques. Together, the
realization of these studies will reveal novel roles of PPT1 in neuronal function and convergent molecular
mechanisms of NCL and aging pathogenesis, which may provide therapeutic targets. Mentorship from a diverse
panel of experts in my proposed techniques will facilitate my training as an independent cellular and molecular
neurobiologist.

Public health relevance
PROJECT NARRATIVE Neuronal Ceroid Lipofuscinosis type 1 (CLN1) is a devastating pediatric neurodegenerative disease characterized by the accumulation of lipofuscin, an autofluorescent lysosomal storage material that also builds up in the brain with normal and pathological aging. This project seeks to uncover fundamental molecular mechanisms that link CLN1-associated and age-associated lipofuscin with the long-term goal of identifying therapeutic targets for neurodegeneration.